Baylor College of Medicine Cancer Center-Cancer Center Support Grant

Dan L Duncan Comprehensive Cancer Center at Baylor College of Medicine
OVERALL - PROJECT SUMMARY
This is the 3nd CCSG competitive renewal application of the Dan L Duncan Comprehensive Cancer Center
(DLDCCC) at Baylor College of Medicine (BCM) in Houston, Texas. Houston is the 4th largest city in the
United States with a very diverse population and Harris County is one of the most rapidly growing in the
country. The DLDCCC Catchment Area has expanded from the core of Harris county to include the 8
surrounding counties which comprise the Houston Metropolitan Statistical Area (MSA), representing a
diverse population of more than 7 million individuals (this population is greater than 35 states). The
DLDCCC is a matrix center with BCM as the lead partner with 4 hospital affiliates, Texas Children’s, the
DeBakey Veterans Affairs Medical Center, Ben Taub Hospital, and the new Baylor St. Luke’s Medical Center
as formal affiliates. The DLDCCC received NCI designation in 2007 and comprehensive designation in 2014
and through our evaluation and planning process and recommendations from our EAC and internal
committees, we have since made significant progress strengthening our scientific programs. 53 new cancer
faculty have been recruited to the DLDCCC which now has 192 Research members, 78 Clinical members and
18 Adjunct members. Our cancer-relevant peer reviewed research funding now exceeds $169 million, with
more than $49 million ($34M direct) coming from the NCI. Several important scientific accomplishments have
been made that have an impact in our Catchment Area and globally. The DLDCCC comprises 7 research
programs: Cell Signaling and Metabolism, Mechanism of Cancer Evolution, Nuclear Receptor, Transcription
and Chromatin Biology, Breast Cancer, Cancer Cell and Gene Therapy, Cancer Prevention and Population
Science, and Pediatric Cancer. Significant investments have strengthened the 10 Shared Resources, which
offer leading technologies. A new shared resource in Advanced In Vivo Cancer Models further enhances our
capabilities. The Clinical Protocol and Data Management Core has been significantly enhanced and accruals
to clinical trials have increased. Accrual of racial and ethnic minorities is outstanding. The Office of Outreach
and Health Disparities which drives COE disseminates new information and services to the community,
especially the underserved. Training and education have been integrated into our Programs through the CRCE
core. In this renewal, we ask for increased funding for our 10 Shared Resources and other expanded activities
important to our mission and goals.

Public health relevance
Dan L Duncan Comprehensive Cancer Center at Baylor College of Medicine OVERALL - PROJECT NARRATIVE Cancer is a leading cause of morbidity and mortality in the United States and globally. The diagnosis and treatment of cancer are extraordinarily demanding and increasingly expensive with major impacts on our economy. Although overall survival from cancer has improved and certain cancers can be prevented or cured, much remains to be accomplished to improve patient outcome through research to develop novel strategies to prevent, diagnose early, and effectively treat this disease. The Dan L Duncan Comprehensive Cancer Center at Baylor College of Medicine has put together a strong multidisciplinary team of scientists, clinicians, educators, and community outreach experts to further improve survival from cancer both in our Catchment Area and globally, and to educate the scientists and clinicians of the future.